Modulators of Secreted ER Ca2+ Monitoring Protein (SERCaMP)

This project aims to identify antagonists of the thapsigargin:SERCaMP interaction, providing potential research tools to enable better characterization of these diseases and guide development of future therapies. During this period, the collaborative team continued medicinal chemistry optimization of previously identified and validated hit scaffolds. In addition to medicinal chemistry activities, some biotin PEG-linked bromocriptine, biotin-diazirine-linked NCGC00442155, and alkyne-diazirine-linked NCGC00442155 analogs were also synthesized to aid with target identification efforts.